Leader cell development and function in Breast Tumor Collective Migration

Project Summary for Parent Grant
Accumulated evidence in human breast cancer and mouse models of breast cancer have shown that tumor
cells invade collectively through the basement membrane (BM) and continue as collective groups to traverse
the collagen-rich ECM to access lymphatic and vascular vessels. Rather than single cells, in the circulation
clusters of heterogeneous circulating tumor cells (CTCs), that also contain tumor-associated stromal cells such
as cancer associated fibroblasts (CAFs), account for >90% of metastases.
To move collectively requires coordinated cell–cell and cell–matrix interactions. Hallmarks of collective cell
migration include: 1) Cells remain physically and functionally connected such that the integrity of cell–cell
junctions are preserved during movement. 2) A subgroup of cells typically defines the leading edge, and thus,
the direction of collective migration. These are known as “leader “cells and differ in function from “follower”
cells. 3) Collective movement also involves intimate interaction with accessory stromal cells that release
polarity-inducing and pro-migratory factors as well as contribute to path finding by physically remodeling the
surrounding ECM.
Several hypotheses have been proposed to explain cancer leader cell development during collective
migration. Yet how these leader cells develop, arrive and define the front edge, then lead directed collective
migration, and whether this phenomenon is necessary and sufficient to effect directed collective migration are
largely unknown. We have developed novel microfluidic devices in which to study the collective migration of
primary breast tumor organoids in response to multiple environmental signals
In the present proposal we propose to use primary breast tumor organoids with their inherent cellular
heterogeneity to determine how leader cells develop and function, in response to multiple environmental
signals, so as to direct collective migration. To do so we propose two specific aims. Specific Aim 1. To
determine how K14 leader cells within primary breast tumor organoids polarize to the leading edge and then
function to direct collective migration. Specific Aim 2: To understand chemo-mechanical feedback between
CAF-based ECM remodeling and leader-based invasion.
Project Summary for Supplement
In breast tumor invasion, clustered cells invade through surrounding stromal collagen to enter circulation. This
process is regulated by leader cells that come to the front of a breast tumor collective and “lead” the entire
organoid to invade collagen. The supplement project asks whether there is an optimal balance of cellular
forces and collagen density and crosslinking. This is a multivariate problem that requires modeling predictions;
it would otherwise be much more difficult to straightaway perform numerous experiments to try all possible
combinations of cell types and collagen compositions. This supplement project studies how dysfunctional cell-
cell communication can alter cell invasion modes in 3D environments of varying stiffness and fiber architecture.
Cell populations are captured in a cellular Potts lattice-based modeling framework and collagen as a 3D field
that can evolve by cellular forces. Modeling parameters corresponding to cell protrusions (regulated by P-
cadherin and Rac), cell-cell adhesions (α-catenin), and cellular contractility (RhoA) are varied in a given cell
population. In parallel, collagen concentration, degradation rate, crosslinking rate, and long-distance force
propagation are also varied. Simulations are performed to measure how invasion modes of these different
populations vary according to fiber microstructure of 3D collagen matrices. The modeling predictions from this
supplement project, particularly relating to the roles of P-cadherin, Rac, α-catenin and RhoA in collective cell
3D invasion, inform other projects in the parent grant.

Public health relevance
Project Narrative for Parent Grant The majority of breast cancer deaths result from metastatic disease. Accumulated evidence indicates that breast tumor cells invade as complex, heterogeneous clusters rather than single cells and to do so they are led by cells called leader cells. How these leader cells develop to lead directed collective migration, and whether this phenomenon is necessary and sufficient to effect directed collective migration is largely unknown. This is a focus of the current proposal. Project Narrative for Supplement Breast tumor microenvironment involves heterogeneities due to varying properties of leader cells, cancer- associated fibroblasts, follower cells, collagen fibers, chemokine gradients, and hypoxia. Both in vivo and in vitro experimentation has revealed different roles for these variables. However, due to inherent complexity and numerous possibilities, computational modeling and validations against experiments are needed to make predictions about breast cancer progression. This supplement will be devoted towards computational modeling and comparisons against experimental results obtained in the parent grant.